ProteinSimple Jess System for Protein Analysis at NYMC

PROJECT SUMMARY
This is a request for Jess Protein Analysis System (Protein Simple) to be integrated into the New York Medical
College (NYMC) for protein quantitation and characterization. NYMC is dedicated to building biomedical
research. A key part of NYMC Strategic Plan is improving investigator-identified critical core research facilities.
Surveys of NYMC funded investigators, including those funded by NIH and those funded from other sources,
consistently rank a protein analysis system that may quantitative and reproducible results as the most essential
core piece of equipment for their current and future research, especially in the absence of a functional
proteomics core. The proposed ProteinSimple Jess System integrated into the College Histological Laboratory
and Imaging Core will meet a tremendous unmet need for investigators for state-of-the art automated size-based
separation and nano-immunoassay platform for the detection and characterization of proteins molecular weights
in denatured protein from tissues, cells, and extracellular particles (extracellular vesicles and extracellular
condensates). The research of many of the Major and Minor Users at NYMC involves analysis of gene
expression at the protein level and the enhanced signal to noise ratio provided by the ProteinSimple Jess System
is essential. Currently there is not a functional proteomics core at NYMC. The proposal includes 4 NIH-funded
Major Users from various departments and disciplines at NYMC. NIH funded users comprise 100% of the
estimated Accessible User Time (AUT) for the instrument. The other users comprise additional investigators with
critical need for quantitative and reproducible results. There is no functional protein analysis core or equipment
at NYMC. All investigators depend on traditional western blotting that is plagued by poor reproducibility, lack of
accurate quantitation, extensive time to result and reliability issues. All Major/Minor Users have agreed that the
ProteinSimple Jess System will best fit the current/future needs of investigators to provide more quantitative and
reproducible results, thus, meeting established guidelines on NIH’s reproducibility and rigor. In addition to the
automation, sensitivity, and throughput advantages of the ProteinSimple Jess System, the system creates
electronic data files that are impervious to manipulation, as it contains the raw and analyzed data, which can
easily be uploaded to a data repository when it comes time to publish. In summary, the ProteinSimple Jess
System promotes data reproducibility because it precisely controls sample loading, antibody additions,
incubations, and all washes, thereby eliminating the inconsistencies and user-dependent variability that
may be introduced during traditional western blotting, culminating in intra-assay Coefficients of
Variability (CVs) <15%.

Public health relevance
PROJECT NARRATIVE This is a shared instrumentation grant for a protein analysis system that may quantitative and reproducible results as the most essential core piece of equipment for their current and future research. This is a critical state of the protein analysis system for investigators at NYMC, who while experienced with protein analysis and molecular biology, currently have no access to proteomics core. The ProteinSimple Jess System is automated, sensitive, and creates electronic data files that are impervious to manipulation, as it contains the raw and analyzed data, which can easily be uploaded to a data repository when it comes time to publish, thus, meeting established guidelines on NIH’s reproducibility and rigor.